Defining the role of the Brucella TIR-NAD hydrolase activity in immunosuppression and pathogenesis

PROJECT SUMMARY
Toll/interleukin-1 receptor (TIR) domains, conserved from archaea to mammals, mediate innate immune
signaling. Multiple bacterial pathogens use secreted TIR domain-containing effectors to modulate hostpathogen
interactions and sabotage host immunity. Recently, bacterial TIR domains were discovered to have
nicotinamide adenine dinucleotide (NAO+) hydrolase activity, depleting host cell NAO- during infection. Since
NAO- levels regulate metabolism, cell signaling and immune function, bacterial TIR-mediated NAO- hydrolysis
is potentially highly relevant for infectious success. However, the role of TIR-NAOase activity in bacterial
pathogenesis remains unknown. This proposal will address this knowledge gap, focusing on Bruce/la species
that are highly pathogenic for humans as a model system. We will test the overall hypothesis that TIRmediated
NAO' hydrolysis directly contributes to bacterial virulence. Aim 1 will determine if TIR-NAO'
hydrolysis contributes to the immunosuppressive properties of Bruce/la TIR domain-containing effectors
BtpA/BtpB by assessing the inhibition of host cell NF-KB activation and inflammatory cytokines in infected
primary macrophages and dendritic cells. This aim will also localize the BtpA/B effectors in infected cells and
determine if the TIR-NAOase activity contributes to the targeting of host TLR-adaptor complexes. Aim 2 will
establish the role of the BtpA/BtpB TIR-NAOase activities in vivo. Using TIR-NAOase catalytic mutants, splenic
inflammation will be quantified in a standard BALB/c murine model of brucellosis. Additionally, the contribution
of NAOase activity to virulence will be assessed in a newly developed, completely penetrant, and clinically
scorable SKG model of Bruce/la-induced spondyloarthritis, the most common chronic complication of human
brucellosis. This project is innovative as it will establish the relevance ofTIR-mediated NAO' depletion in the
context of mammalian infection, both in vitro and in vivo. Moreover, this work will validate a new model of
Bruce/la-induced spondyloarthritis and its use for dissecting the bacterial mechanisms implicated in chronic
brucellosis, for which no model is currently available. The proposed work is highly significant and aligns with
the mission of the NIH in that it will define the mechanisms of host immune evasion by this important family of
bacterial secreted effectors, potentially resulting in a paradigm shift in our understanding of how bacterial TIR
domains contribute to host-pathogen interactions and pathogenesis. The results generated will have a broad
impact given the number of bacteria associated with human infectious diseases containing TIR-effector
proteins with NADase activity. Finally, targeting TIR-NADase activity may offer a promising new therapeutic
approach for infectious diseases.

Public health relevance
PROJECT NARRATIVE Many bacterial pathogens have been shown to use bacterial proteins with a TIR domain for suppression of the host immune responses and to cause disease. Here we will investigate a newly identified enzymatic activity of these TIR domains to determine how it contributes to pathogenesis.